Biomechanics and mechanobiology of human uterine fibroids

PROJECT SUMMARY/ ABSTRACT
Uterine fibroids are the most prevalent noncancerous growths that form within the female body, present in 70 -
80% of women by age 50, and may result in severe pain, heavy menstrual bleeding, infertility, and preterm labor.
Uterine fibroids are characterized by stiff, collagen-dense masses of tissue that exhibit a large degree of
heterogeneity in terms of size, location, gross architecture, and composition, however, the mechanisms by which
uterine fibroids initially form and grow are poorly understood. As such, current treatments are limited, relying
primarily on surgical means of removal, which are associated with high recurrence rates. To address key
knowledge gaps in the literature, this proposal will take a multifaceted, engineering-based approach to
investigate uterine fibroid pathophysiology ex vivo and in vitro. I hypothesize that the altered mechanical
microenvironment of uterine fibroids highlights underlying structural and compositional changes to the tissue,
which in tum alters cell signaling pathways, namely mechanotransduction. In Aim 1, I seek to study the spatial
variation in mechanical, structural, and compositional properties of small, medium, and large fibroids at the
myometrium interface ex vivo to establish a categorization scheme for fibroids of all sizes. I expect uterine fibroids
to exhibit increased stiffness and collagen content relative to patient-matched myometrium, regardless of fibroid
size, demonstrating a significant degree of intra- and inter-fibroid variability with a sharp transition in material
properties at the interface. This data will be foundational in the development of a novel endoscope for improved
intrauterine detection and for drug delivery assessments. In Aim 2, I seek to elucidate the pathophysiology of
uterine fibroids on the cellular level and quantitatively assess the role of mechanotransduction through targeted
modulation in vitro. Specifically, I hypothesize that uterine smooth muscle cells (uSMCs) derived from fibroids
will exhibit reduced responsiveness to different substrate stiffnesses and overexpression of focal adhesion
kinase (FAK), a key mechanotransductive molecule, when compared to myometrial uSMCs. I further hypothesize
that FAK inhibition of fibroid uSMCs will alter the cell behavior in such a way as to mimic the healthy myometrial
phenotype. As such, this study will establish the validity of FAKi as a novel pharrnacologic treatment of uterine
fibroids. In summary, given our team's strong expertise in soft tissue biomechanics, mechanobiology, materials
science, ultrastructural imaging, and gynecologic health, the proposed study will generate foundational data in
the characterization of uterine fibroid heterogeneity and the mechanisms by which fibroids develop and grow.
Henceforth, I plan to leverage these findings in future work to develop clinically translatable diagnostic tools and
treatment approaches for uterine fibroids.

Public health relevance
PROJECT NARRATIVE Uterine fibroids are noncancerous tumors that form within the uterus, affecting nearly 70 - 80% of women in their lifetimes, and are a major cause of severe pain, bleeding, and infertility. Yet, despite its high prevalence and significant disease burden, current treatment options are limited, relying primarily on surgical means of removal, with innovation hampered by a poor understanding of the underlying disease pathophysiology. Therefore, this research proposal seeks to establish fundamental knowledge regarding the structure, function, and mechanics of uterine fibroids through a multi-scale, multi-faceted engineering-based approach to directly improve the diagnosis and treatment of uterine fibroids.